Bone Marrow Grafting and Cellular Therapy for Leukemia and Lymphoma

Project Summary/Abstract:
Hematopoietic cell transplantation (HCT) and cellular therapies are effective treatments for a broad range of
hematological malignances, representing the first successful and widely applied cellular therapy for cancer. In
this revised Program Project Grant competitive renewal (years 34-38), we will probe the cellular basis of
transplantation biology (Project 1 and 3) and cell therapies with novel cellular populations, including iNKT cells
(Project 1), CAR T cells (Projects 2 and 3), Treg cells (Project 2) and novel antibody constructs (Project 4).
The overall goals of our Program Project Grant are to develop a more robust fundamental understanding of
transplantation biology and cellular therapies and to address the major challenges of HCT including reducing
transplantation risks, preventing graft-vs-host-disease (GvHD) and disease relapse. We will utilize innovative
animal modeling, comprehensive biological and molecular analysis, novel imaging and biologically focused
translational clinical trials. Our Program involves four highly interactive Projects focusing on: addressing
transplantation risk (Projects 3 and 4), the biology and prevention of GVHD (Projects 1, 2 and 3), prevention
and treatment of disease relapse with iNKT cells (Project 1), CAR T cells (Project 2 and 3) and targeted
immunotherapy strategies focused on the stem cell antigen CD117 (Project 4). These Projects are supported
by 3 Cores (Administration, Biostatistics and Data Management and Correlative Sciences). Through our highly
interactive Program Project, we will gain novel insights into the biology of HCT and cellular therapies and develop
innovative strategies to improve outcomes for patients with hematological malignancies. The knowledge gained
has profound implications for extending these therapies to other cancers and for the treatment of patients with a
broad range of immunological conditions such as autoimmune disorders and organ transplantation.

Public health relevance
Narrative Our goals through this highly interactive Program Project Grant are to develop a more fundamental understanding of transplantation biology and cellular therapeutics through a combination of preclinical models and extension to novel well constructed clinical trials.